Exploring Mechanisms of Cardiac Pacemaker Cell Fate Determination

Exploring mechanisms of cardiac pacemaker cell fate determination
PROJECT SUMMARY
Pacemaker (PM) cells reside within the sinoatrial node (SAN), which faithfully initiates over 3 billion heartbeats
during the human lifespan. PM dysfunction often necessitates device implantation to prevent circulatory collapse
from bradycardia. Despite the critical importance of cardiac PM function, the mechanisms by which PM cells
undergo lineage commitment remain obscure. The long-term goal of our research program is to understand the
mechanistic basis for cell fate determination within the cardiac conduction system. The overall objective for this
proposal is to explore molecular strategies for PM cell lineage commitment. There is an urgent need to elucidate
the molecular underpinnings of PM lineage commitment to understand the fundamental biology of PM fate de-
termination and to inform future development of new therapeutic strategies. My lab recently reported on key
mechanisms by which Hand2 regulates PM formation using conversion of fibroblasts into induced PM myocytes
(iPMs) as a model system. Building upon this preliminary data, our central hypothesis is that Hand2 interacts
with AP-1 to promote subtype diversity and cooperatively binds genomic targets to orchestrate PM specification.
To test our central hypothesis, we propose the following Specific Aims: 1) Define the mechanisms by which
Hand2 ensures cardiac subtype diversity, 2) Explore the basis for cardiac PM lineage commitment and alterna-
tive fate restriction, and 3) Boost iPM reprogramming by component annotation and combinatorial perturbation.
In Aim 1, we will use our iPM reprogramming system in conjunction with genomic occupancy analysis, co-im-
munoprecipitation, immunocytochemistry (ICC), single-cell RNA sequencing (scRNA-seq), and confocal micros-
copy to define biochemical interactions, perturb cardiac reprogramming, and characterize the resulting cell fates.
In Aim 2, we will use scRNA-seq, cell fate trajectory mapping, ICC, genomic occupancy analysis, and protein-
binding microarrays (PBMs) to analyze lineage regulators, alternative fate repressors, and combinatorial inter-
actions during iPM reprogramming. In Aim 3, we will systematically annotate candidate factors curated from our
preliminary data and the literature. In parallel, we will build PM regulatory networks from the ground-up using
novel combinatorial genomic approaches that we have recently developed. Successful completion of the pro-
posed project will provide critical details regarding the establishment and maintenance of PM cell identity. This
contribution will be significant because it will provide detailed insight into how cell fate is accomplished and
identify potential regulators and mechanisms of PM specification. Furthermore, the proposed research is inno-
vative because our unique experimental approaches and multi-disciplinary research team promise to uncover
new principles in cell fate determination. Taken together, we anticipate that the results of the proposed project
will provide detailed knowledge of the gene regulatory networks that drive PM cell specification and guide future
development of novel strategies to engineer therapeutic replacement cells for sinus node dysfunction.

Public health relevance
PROJECT NARRATIVE Pacemaker cells are responsible for faithfully initiating every heartbeat, yet the mechanisms responsible for their formation and maintenance are not well-understood. Direct reprogramming of fibroblasts into functional cardiomyocytes, including pacemaker cells, has recently emerged as a viable approach for studying lineage specification, but many details of the process remain poorly characterized. Using an innovative and multi- disciplinary approach, we propose to examine pacemaker reprogramming mechanisms to better understand pacemaker formation and to eventually develop cellular replacement strategies for patients with sinus node dysfunction.